Mechanisms of axonal protection by astrocytes and microglia inAlzheimer disease

PROJECT SUMMARY
Microglia and astrocytes have long been suspected of participating in the pathogenesis of Alzheimer’s disease
(AD). However, it is not clear how these cells orchestrate their reactions in AD and whether they play protective
or deleterious roles that can be targeted therapeutically. We recently discovered a potentially neuroprotective
function that we termed the “microglia barrier”. We found that the robust encapsulation of Aβ deposits by
microglia processes cause Aβ aggregates to become compact, less toxic and insulated from adjacent neurites,
thereby reducing the formation of dystrophic axons. This neuroprotective function was severely disrupted in mice
lacking Trem2 or Dap12, which have defects in microglia polarization towards plaques, leading to a more diffuse
plaque conformation and worsening of axonal dystrophy. In this proposal, we aim to explore the possibility that
in addition to microglia, the astrocytic reaction to early amyloid aggregates and the coordinated reaction between
these two cell types is critical for the overall glial protective function. We will utilize sophisticated super-resolution
imaging of mouse and human brain, intravital optical imaging and in vivo single cell manipulations to investigate
the cellular and molecular basis of astrocyte and microglia orchestrated interactions and polarization towards
amyloid deposits. We will also explore signaling pathways that can be targeted to enhance this neuroprotective
glial barrier and reduce AD-associated axonal pathology.

Public health relevance
PROJECT NARRATIVE We have discovered that microglia play a critical role in compacting and insulating amyloid plaques, which renders them less toxic to adjacent neuronal processes. We are proposing to utilize sophisticated live imaging and high-resolution microscopy combined with molecular manipulations to investigate how microglia interact with another cell type, astrocytes, during the protective encapsulation of amyloid plaques. We hypothesize that coordinated encapsulation by these two glial cells is critical for preventing damage to adjacent axons. We hope that this interaction can be exploited therapeutically to diminish the progression of neural dysfunction in Alzheimer disease.